IGF::OT::IGF Logistical support for even titled, "Role of Long Non-coding RNAs in Cardiovascular, Lung, and Blood Diseases"

The National Heart, Lung, and Blood Institute convened a Working Group (WG) on June 1-2, 2016 in Bethesda, Maryland, to discuss Role of Long Non-coding RNA in Cardiovascular, Lung, and Blood Diseases.